Administrative Core

PROJECT SUMMARY/ABSTRACT
Under the direction of Executive Director Walter J. Curran, Jr., MD, Winship has continued to enhance its
administrative team and its functionality through process improvements, staff restructuring, and growth. Senior
Director for Cancer Research Administration Kimberly Kerstann, PhD oversees Winship Administration.
Kerstann sets the Winship administrative priorities to facilitate the strategic advancement of collaborative cancerrelated research in a matrix organization. Winship Administration assists the Executive Director, senior
leadership, program leaders and co-leaders, shared resource directors, and members in fulfilling the mission of
Winship by offering highly effective administrative management, program planning, and centralized services.
The administrative unit supports faculty and staff involved with the CCSG and its related activities, occupants of
Winship space, recipients of Winship pilot grants and philanthropic funds, participants in cancer disease site
working groups and programs, and participants in clinical oncology investigation. Winship Administration has
continued to seek guidance from internal and external advisors and act strategically to position itself for growth.
Winship’s senior leadership team is comprised of Executive Director Walter J. Curran, Jr., MD; Deputy Director
Suresh Ramalingam, MD; Associate Director for Population Sciences Carla Berg, PhD; Associate Director for
Mentorship, Education, and Training Deborah Bruner, PhD, RN; Associate Director for Basic Science Paul
Doetsch, PhD; Associate Director for Clinical Research Bassel El-Rayes, MD; and Senior Director for Cancer
Research Administration Kimberly Kerstann, PhD. Senior leadership oversees the advancement of Winship’s
scientific priorities, Winship’s research programs and shared resources, Winship’s education, training, and
mentorship efforts, Winship’s multi-investigator, multi-disciplinary, and translational science, and its cancerrelated clinical research. Senior leadership is also responsible for developing and executing Winship’s strategic
planning process.